ALCAM-mediated cell adhesion and extracellular vesicle biogenesis in bladder cancer

PROJECT SUMMARY Extracellular vesicles (EVs) are a heterogenous group of lipid bilayer enclosed particles secreted from cells and are found in most, if not all, biological fluids. The term EV encompasses a wide range of vesicle classes, including exosomes (50-150 nm) and microvesicles (150 nm - 1000+ µm), derived from the endosomal pathway after fusion of multivesicular bodies with the plasma membrane or from direct budding from the plasma membrane, respectively. EVs are further characterized by membrane and luminal cargoes that give rise to distinct functional properties. An emerging body of literature suggests that EVs are major contributors in cell-cell communication in normal physiology and pathological events, such as cancer. EVs have been shown to affect cancer cell chemotaxis and metastatic organotropism. Notably, a specific class of EV is dependent upon syntenin-1, an adaptor protein that contains two PSD95/Dlg/zonula occludens 1 (PDZ) domains, for biogenesis and cargo loading through the endosomal pathway. This suggests that upstream effectors which bind to syntenin-1 could modulate its availability, and in turn, regulate exosome biogenesis and cargo loading. Activated Leukocyte Cell Adhesion Molecule (ALCAM) is an adhesion protein in the immunoglobulin superfamily found at sites of cell-cell junctions. ALCAM is a dynamic regulator of cell adhesion through differential shedding of its ectodomain. Our laboratory demonstrated that the full-length ALCAM Isoform (Iso1) resists shedding, promotes adhesion and limits metastasis. Conversely, the alternatively spliced isoform 2 (Iso2) is susceptible to shedding, facilitates motility and metastasis. ALCAM shedding and elevated expression of ALCAM Iso2 correlates with bladder cancer (BCa) disease progression. ALCAM can be linked to EV biogenesis through its association with the cytoplasmic scaffolding protein syntenin-1. Sequestering syntenin-1 via the cytoplasmic tail of ALCAM abrogates motility and metastasis, further underscoring the functional relevance of the regulatory mechanism. Additional preliminary studies revealed that the expression of Iso1 suppresses large EV biogenesis while Iso2-facilitates the biogenesis of large EVs. Based on these findings we hypothesize that ALCAM shedding controls syntenin-dependent EV biogenesis in tumor cells. In addition, we hypothesize that ALCAM-mediated adhesion can control the pro-migratory function of EVs by regulating their cargo. To test this hypothesis, I will utilize cell lines expressing different isoforms of ALCAM and BCa patient-derived plasma to determine the mechanism in which ALCAM-mediated cell adhesion affects EV biology. Experiments proposed in Aim 1 will investigate how modulation of a cells' adhesive state through ALCAM expression alters EV biogenesis and function. EV biogenesis will be assessed through complementary techniques of nanoparticle tracking analysis, western blotting, and microflow cytometry. EV function will be determined with the avian embryo model of metastasis and a 3D organotypic bladder model. Aim 2 will characterize the changes in EV cargos upon ALCAM shedding and disease progression in BCa through palmitoylated-mass spectrometry. Collectively, these data will define a relationship between cell adhesion EV biology, both mechanistically and functionally. Additionally, these findings will identify informative molecular markers to aid in the monitoring of disease state through a non-invasive means.

Public health relevance
PROJECT NARRATIVE The contribution of extracellular vesicles to cancer metastasis is defined by their mode of biogenesis. The proposed research will investigate how tumor cell adhesion regulates extracellular vesicle biogenesis and its subsequent contribution to cancer metastasis. This work will therefore describe a link between cell adhesion and extracellular vesicle biogenesis and provide critical information for monitoring disease progression.